Early mitigation of neural inflammation for prevention of trauma-induced heterotopic ossification

Project Summary:
Trauma-induced Heterotopic Ossification (tHO) is an extremely painful condition, caused by
aberrant bone formation in severely injured soft tissues, with no effectual prophylaxis or treatment.
The recent observation that tHO initiation is linked to nociception induced neuroinflammation
(NINI), offers a potential therapeutic target. This proposal presents a four-year research career
development plan focused on modulating NINI to mitigate tHO formation. The candidate is a
board-certified Plastic Surgeon with fellowship training in upper extremity and peripheral nerve
surgery, who decided to pivot to a research-oriented academic tract, to study this devastating
pathology, given the high prevalence of tHO in high-impact injuries in the candidate’s practice at
a Level I trauma center. This proposal builds on his clinical expertise, prior research on
osteogenesis, and merges them with two new domains of expertise represented by his mentors
Dr. Sean Adams (Vice Chair of Research, UC Davis) – inflammation; and Dr. Benjamin Levi (Chair
of Burn Surgery, UTSW) – tHO. The proposed work, didactics, mentorship, and unencumbered
research time, will raise the level of the candidate’s science, establish credibility in the tHO
research space, and ensure his successful transition to an impactful researcher. Trauma-induced
nociception results in sensory nerve over-expression of neuroinflammatory peptide Calcitonin
Gene-Related Peptide (CGRP), which activates the Bone Morphogenic Protein (BMP) pathway,
causing osteogenic differentiation of resident progenitor cells. Targeted Muscle Reinnervation
(TMR) is a peripheral nerve transfer procedure that connects amputated nerve stumps to motor
branches in the residual limb of amputees, and significantly reduces pain and neuroinflammation.
It is only indicated in cases with intractable pain or phantom pain. Fremanezumab is a CGRP
inhibitor currently used in migraine but has not been considered for tHO. The central hypothesis
of this proposal is that reducing NINI surgically (TMR) or medically (Fremanezumab) will diminish
sensory nerve CGRP expression and ultimately tHO formation. This will be investigated using an
in vivo rodent model to test the efficacy of TMR; and a neuroinflammatory in vitro model to test
the efficacy of Fremanezumab. Utilizing existing surgical and medical modalities to inhibit NINI in
tHO is innovative not only because of their translational potential, but also because of the novel
mechanistic insight they provide into tHO initiation and the role of sensory nerve-stem cell
communication in it.

Public health relevance
Project Narrative: Traumatic Heterotopic Ossification (abnormal formation of bone within injured soft tissues) is an extremely painful and debilitating sequelae of high-energy traumatic amputations (such as motor vehicle accidents, crush injuries, combat injuries, etc.), with no realistic prophylaxis or effectual treatment. Pain induced inflammation within the injured tissue has recently been linked to the transformation of resident stem cells to form bone forming cells (osteoblasts). Inhibiting this pain- induced inflammation either surgically and/ or medically could not only prevent bone formation, but also reduce the severe pain associated with this condition and improve the quality of life of amputees.